Expanded Access Deoxynucleoside Therapy for Thymidine Kinase 2 (TK2) Deficiency

Thymidine kinase 2 (TK2) is required for synthesis of pyrimidine deoxynucleoside triphosphate
building blocks for mitochondrial DNA (mtDNA) synthesis. Autosomal recessive TK2 mutations
cause depletion and multiple deletions of mtDNA that manifest predominantly as a myopathy
usually beginning in childhood and progressing relentlessly. Based upon our pre-clinical studies
in a Tk2 H126N knockin mouse model demonstrated efficacy of deoxynucleoside monophosphate
and deoxynucleoside therapies, we have administered these treatments to 30 patients
internationally on an expanded access basis. In a retrospective analysis of 16 genetically
confirmed TK2 deficient patients who had received treatment for at least one year, we observed
stabilization or improvements of clinical functions. In the subgroup of 5 patients with early onset
and severe disease, survival and motor functions improved significantly compared to historical
untreated patients. In the 11 childhood- and adult-onset patients, all clinical measures stabilized
or improved. We observed increases in the 6-minute walk test. Three of 8 patients who were non-
ambulatory at baseline gained ability to walk on therapy; 4 of 5 patients who required enteric
nutrition were able to discontinue feeding tube use; and 2 of 10 patients who required mechanical
ventilation became able to breathe independently. The only side-effect observed in 8 of the 16
patients was dose-dependent diarrhea, which did not require withdrawal of treatment. While our
preliminary data on safety and efficacy of expanded access deoxynucleoside therapy in TK2d
patients are very promising, there are potential concerns about long-term safety and efficacy of
deoxynucleoside therapy that warrant further investigation in this proposed open-label expanded
access multi-center NAMDC study involving three sites.

Public health relevance
There are no FDA-approved therapies for mitochondrial diseases. This expanded access study will assess long-term safety and efficacy of deoxynucleoside therapy for thymidine kinase 2 deficiency (TK2d), a novel treatment that is currently licensed to a bioincubator company for potential commercial development. Assessment of outcome measures in this study will inform future investigation of mitochondrial diseases.